Neural Mechanisms of Habit Formation for Behaviors Motivated by Drugs of Abuse and Natural Reward

7. Project Summary/Abstract
The overall objective of this proposal is to shed light on neural circuits underlying the transition from recreational
to compulsive drug use, and, in doing so, to provide the candidate with training in advanced techniques to study
the neural circuitry involved in drug use and abuse.
Substance use disorders are characterized by compulsive drug use in spite of negative consequences, which
might arise from the development of strong drug-taking “habits.” These habits consist of rigid, inflexible drug-
seeking behavior, and they stand in contrast to “goal-directed” drug-seeking, which is more flexible and driven
by pursuit of a desired outcome (e.g. a euphoric state or relief from withdrawal). Habits can arise from behavior
motivated by either natural reward (e.g. food) or drugs, and behavior that is initially goal-driven can transition to
habitual control. Studies have shown that the shift from goal-driven behavior to habit is accompanied by a shift
in behavioral control from the ventral to the dorsal striatum, and recent evidence suggests that this intra-striatal
shift is “downstream” of a shift from the basolateral amygdala (BLA), to the central amygdala (CeA). However,
direct evidence for this theory is lacking, especially in the form of a signaling mechanism. Moreover, although
there is evidence that dopaminergic input to the BLA and CeA is essential for the maintenance of cued drug-
seeking, it is unclear how dopamine receptors in the amygdala are involved in the initiation of drug-taking or the
formation of drug-seeking habits.
Therefore, the candidate will pursue three sets of experiments, each examining the transition from goal-directed
to habitual behavior in the context of both natural reward and cocaine self-administration: (1) recording neural
activity simultaneously in the BLA and CeA, (2) using an optogenetic strategy to stimulate or inhibit dopaminergic
input to the BLA or CeA, and (3) using a chemogenetic strategy (DREADDs) to inhibit specific projections from
the medial prefrontal cortex (mPFC) to the BLA or CeA. In this way, the proposed experiments will elucidate the
signaling mechanism, the role of dopamine, and the role of divergent mPFC inputs in BLA/CeA control of goal-
directed vs. habitual behavior.
During the award period, the candidate will undergo rigorous training in the techniques and theory underlying
self-administration studies of substance use and addiction. The candidate will also gain training and experience
in advanced techniques for neural circuit dissection, including optogenetics and chemogenetics. This work will
take place in both the candidate’s dedicated lab space and the labs of the candidate’s unique cross-departmental
advisory committee, all within the flourishing neuroscience community of the University of Pittsburgh. In addition,
training will focus on publishing, grantsmanship, and job search skills, effectively preparing the candidate to
apply for larger grants and a tenure-track position within five years.

Public health relevance
8. Project Narrative A major feature of substance use disorders is compulsive drug use: habitual drug-seeking behavior that is rigid, inflexible, and often triggered by particular cues and contexts in the user’s environment. The experiments in this proposal will help us understand the brain mechanisms by which drug-seeking, like other forms of reward- seeking, can initially be “goal-directed” – i.e., driven by the pursuit of a desired outcome, such as euphoria or relief from withdrawal – and later become habitual. In particular, we will investigate how different parts of the amygdala, a brain area involved in forming associations between cues and rewards, are involved in the initial acquisition of reward seeking vs. the formation of habits.